SCGE Administrative Supplement

PROJECT SUMMARY / ABSTRACT
The Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools supports studies
with nonhuman primates that will advance the genome editing field, and significantly contributes to the future
translation of these technologies for the treatment of human disease. The Nonhuman Primate Testing Center
includes a robust team and partnerships that capitalize on major strengths including the California National
Primate Research Center, Genome Center, and Clinical and Translational Science Center. The Nonhuman
Primate Testing Center offers state-of-the-art capabilities for Somatic Cell Genome Editing (SCGE) awardees
to conduct high quality research in nonhuman primates. The Testing Center leverages a supportive framework
that has demonstrated a long-standing commitment to providing research opportunities and collaborations to
investigators nationwide. Through this powerful infrastructure the Testing Center fosters partnerships with
SCGE awardees through provision of expertise, resources, and collaborative opportunities that accelerate their
research, and ensures synergism across the SCGE Consortium and with ongoing interactions with the
Dissemination and Coordinating Center. This supplement provides equipment that addresses the basic
functions of the Testing Center and the provision of services to investigators across the SCGE Consortium.

Public health relevance
PROJECT NARRATIVE The Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools serves the Somatic Cell Genome Editing community and the public by supporting studies in nonhuman primates that will advance the field. Through these efforts the Nonhuman Primate Testing Center significantly contributes to the future translation of cutting-edge technologies for the treatment of a range of rare and common human diseases.